THE EFFECT OF SMOKING ON THE PATTERN OF NEURAL SYMPATHETIC OUTFLOW IN PREMENOPAU

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To determine if muscle sympathetic nerve activity maintains its normal fluctuation over the menstrual cycle in women smokers, as it does in non-smokers.